NONHUMAN PRIMATE CORE CELLULAR IMMUNOLOGY LABORATORY FOR AIDS

To support the conduct, improvement, and development of assays designed to evaluate and characterize the cellular immune responses of Non Human Primates (NHP)s that have been immunized with candidate HIV or SIV vaccines or infected with SIV, SHIV, or HIV in studies conducted at the NIAID SVEU contract sites or by NIH-supported investigators.